Expandable Pediatric Pulmonary Heart Valve

PROJECT SUMMARY
EXPANDABLE PEDIATRIC PULMONARY HEART VALVE
About 1-2% of people are born with a heart valve defect, with the most common being a bicuspid aortic valve
with pulmonary valves following. To treat newborns with severe heart valve defects, surgeons need small
diameter valves that can grow larger with the patient and double in size within 20 years. Such devices do not exist
in the marketplace. Due to this technology gap, the family and care team is faced with a palliative treatment
approach of waiting as long as possible before implanting an oversized valve with several open-heart re-
interventions every couple of years, when they outgrow or outlive their initial valve device. In addition to the
safety and outcomes issues above, the financial and emotional burden for these patients, their families, and the
medical system at large is huge, especially when an infant or child could need 3-4 valve replacement surgeries in
their lifetime.
A replacement heart valve is needed that can provide a “once and done” solution for these children who are
facing multiple valve replacements in their lifetime. We hypothesize that an expandable surgical valve will meet
this demand. We designed a novel expandable stent that can be extended as needed, onto which stabilized and
anti-calcification treated elastic tissue is attached as a tri-leaflet valve. When tested in a bioreactor, valves
expanded by 50% and 100% using balloons while functioning well hemodynamically.
In the current project, we propose 1) optimizing the stent design and 2) testing the valve device in a juvenile
pig model. The research team is led by Dr. Leslie Sierad, with expertise in bioreactor development and valve
design and manufacturing; Dr. Dan Simionescu, with expertise in scaffold generation and tissue analysis; and Dr.
Minoo Kavarana, a pediatric cardiac surgeon with expertise in animal studies. We expect this device to exhibit
adequate hemodynamics and biocompatibility, thus advancing the field of artificial heart valves for pediatric
patients.

Public health relevance
PROJECT NARRATIVE EXPANDABLE PEDIATRIC PULMONARY HEART VALVE Many children are born with heart disease, and some of them need a valve replacement. However, there is no valve on the market that can be implanted in babies and that can grow in size with them. Because of this gap, surgeons need to operate on the children 3-4 times in their lifetime, subjecting the patients, their families, and the healthcare system to extreme risks and high costs. In response, we are developing an expandable heart valve that can be implanted in children and can be expanded gradually using minimally invasive methods until the patient reaches maturity.